DIETARY SELENIUM IN MOUSE INTESTINAL TUMORIGENESIS

The mineral selenium (Se) prevents tumor development in experimental animals. Many epidemiological studies suggest that dietary Se is inversely correlated to human carcinogenesis. Recently, a double-blind study using moderate doses of Se has demonstrated a significant reduction in human cancer incidence at several sites, including lung, prostate and intestine. Most rodent experimental studies that have employed Se as a chemopreventive agent have relied on the use of pharmacological doses of Se to prevent tumor induction mediated by chemical carcinogens. The relevance of these studies to human carcinogenesis is unclear, and despite decades of research, these studies have failed to elucidate the mechanism of action of Se in chemoprevention. This proposal is based on a novel approach to determine the role of Se in human chemoprevention using the mouse as a model system. We hypothesize that the role of Se in human chemoprevention can be replicated in the mouse with the use of physiological levels of Se and that these effects will be most relevant to human carcinogenesis with the use mouse strains carrying defined mutations in genes involved in human carcinogenesis. We will test the role of dietary Se in the Min model of familial adenomatous polyposis (FAP) and the Mlh1-/-mouse model of human hereditary nonpolyposis colorectal cancer (HNPCC) that we have recently developed. Additionally, we hypothesize that at physiological doses of Se, chemoprevention mechanisms are mediated through alterations in the level of oxidative stress. We will determine if modulation of oxidative stress by Se affects tumor development through a direct effect on genomic stability, or indirectly through the inhibition of pathways that are normally induced by oxidants in the intestine, such as cyclooxygenase-2 (COX-2).